Vaccine-mediated cross-alphavirus protection for a live attenuated FDA licensed chikungunya virus vaccine

Project Summary/Abstract
Chikungunya virus (CHIKV) is an emerging mosquito-borne alphavirus endemic in 110 countries that causes
febrile illness and arthritic disease. In November 2023, FDA approved the first CHIKV vaccine, a live attenuated
vaccine (LAV) marketed as IXCHIQ. Although there are many important human pathogenic alphaviruses with a
near global distribution, IXCHIQ is the first alphavirus vaccine licensed for humans. No studies have evaluated
the ability of IXCHIQ to protect against infection, viremia, and disease after exposure to other alphaviruses that
also occur in Latin America in areas with CHIKV or determined how prior heterologous alphavirus infection
impacts IXCHIQ efficacy. This information is important to know as it will identify impacts of IXCHIQ campaigns
in contexts where the vaccine is administered to populations with or without prior alphavirus exposure. As a LAV,
IXCHIQ produces human viremias up to 5 log10 genomes/ml that peak at 3 days and last 1 week. These viremias
exceed infection and transmission thresholds for CHIKV vector mosquitoes Aedes aegypti and Aedes albopictus
in studies we and others performed with the same or nearly identical CHIKV strains as the backbone used for
IXCHIQ. However, no studies have examined whether IXCHIQ is capable of transmission by mosquito vectors.
If IXCHIQ is transmitted by Aedes, it could be spread by mosquitoes infected from viremic vaccinees, leading to
infection of children, immunosuppressed, and pregnant people for which the vaccine is not approved. The goals
of this project are to understand alphavirus circulation dynamics in the novel landscape of IXCHIQ rollout. These
goals will be accomplished via the following 3 project Aims: 1) Determine cross-protective efficacy of IXCHIQ-
induced immunity against heterologous alphavirus species and define the role of cross-reactive antibody in
protection, 2) Define infectivity and transmissibility of IXCHIQ in Ae. aegypti and Ae. albopictus mosquitoes and
determine protective efficacy of mosquito-delivered IXCHIQ, and 3) Determine the impact of prior infection with
a heterologous alphavirus on IXCHIQ-induced immune responses and efficacy against CHIKV and define the
role of cross-reactive heterologous antibody in protection or disease enhancement. We will use 4 heterologous
alphavirus species that occur in Latin America where IXCHIQ rollout is expected as well as CHIKV in established
mouse and non-human primate models, including a new Mayaro virus rhesus macaque model we developed.
This project will identify consequences of IXCHIQ rollout in contexts where the vaccine is administered to people
with or without prior alphavirus exposure and it will define the potential for mosquito-borne IXCHIQ spread in
areas with Aedes, which can inform recommendations for recent vaccinees to prevent mosquito exposure. If
IXCHIQ protects against disease caused by other alphaviruses, vaccine rollout could reduce incidence and
burden of other alphaviruses in addition to CHIKV.

Public health relevance
Project Narrative In November 2023, FDA licensed IXCHIQ, the first chikungunya virus vaccine. This project aims to define alphavirus circulation dynamics in the novel landscape provided by IXCHIQ rollout. This will be accomplished by defining IXCHIQ-mediated protection against disease caused by other human pathogenic alphaviruses, evaluating potential for mosquito-borne IXCHIQ transmission, and determining the impact of prior alphavirus exposure on IXCHIQ efficacy against chikungunya virus infection.